Developing and establishing the content validity of a patient reported experience measure for the kidney transplant evaluation process

PROJECT SUMMARY/ABSTRACT
Transplant is a valuable treatment option for many people with kidney failure, but in order to receive a kidney,
patients must first be referred to a transplant center and complete a process of physical and psychosocial
evaluation. Nephrologists and dialysis organizations are increasingly incentivized to refer greater numbers of
patients with kidney failure to transplant centers in an effort to improve equitable access to this treatment. Such
efforts can also be expected to increase the number and clinical complexity of patients engaging in the
evaluation process. However, many patients will not ultimately receive a kidney and the evaluation process
itself can be demanding, opaque, and lengthy and can take an emotional and psychosocial toll for patients and
families. As more patients are drawn into this care process, multiple national stakeholder groups have
emphasized the importance of minimizing burdens and improving patient experience. However, efforts to
improve this patient experience are hampered by a lack of validated measures. In recent years, leading
professional societies, regulators, and patient communities have called for the development of patient-reported
outcome measures of the pre-transplant process.
The aim of the proposed work is to develop and establish the content validity of a Kidney Transplant Evaluation
Patient Reported Experience Measure (KTE-PREM). In Phase 1 (concept elicitation), we will perform a
structured literature review, analyze existing qualitative interview transcripts, and conduct focus groups with
patients who were referred to a transplant center, their family members, and clinicians who care for these
patients (including primary nephrologists, social workers, and transplant team members). Patients will be
recruited from Northwest Kidney Centers (a large non-profit dialysis organization based in Washington state
which typically refers patients to three regional transplant centers) and the University of Washington. These
sequential steps will result in a comprehensive set of concepts potentially relevant to a KTE-PREM. In Phase 2
(concept prioritization), we will identify items most relevant to patients to be included in a KTE-PREM by
conducting a national survey among patients receiving care at two large non-profit dialysis organizations
(Northwest Kidney Centers and Dialysis Clinic, Inc) who were referred to a kidney transplant center. In Phase 3
(instrument construction and refinement), we will design a draft KTE-PREM and iteratively refine the instrument
through cognitive interviews with a local group of patients who were referred to a kidney transplant center.
The proposed work directly extends from Dr. Butler’s recent NIH/NIDDK supported research (K23DK129777),
which has identified a need and opportunities to improve person centricity of the kidney transplant evaluation
process. Following development of the KTE-PREM, additional funding will be sought for validation. We
anticipate that this validated instrument will have applications in clinical, research, and policy work intended to
measure and improve patient experience in the kidney transplant evaluation.

Public health relevance
PROJECT NARRATIVE Transplant can be a valuable treatment option for people with advanced kidney disease but in order to receive a kidney, patients must complete a physical and psychosocial evaluation process that can be demanding, complex, lengthy, and opaque. We propose to develop and establish the content validity of a Kidney Transplant Evaluation Patient-Reported Experience Measure (KTE-PREM) that will represent what is most important in the experience of patients who engage in this consequential care process. We anticipate that a validated KTE-PREM would support clinical, research, and policy initiatives to evaluate and improve the experiences and outcomes of patients with kidney failure undergoing transplant evaluation.